2023 Salivary Glands and Exocrine Biology GRC and GRS

PROJECT SUMMARY
This proposal requests partial support for the thirteenth Gordon Research Conference (GRC) and the third
Gordon Research Seminar (GRS) entitled Salivary Glands and Exocrine Biology: Understanding the Biology of
Secretory Function and Diseases of Exocrine Tissues to be held from Back January 29th-February 3rd, 2023, at
the Four Points Sheraton hotel in Ventura, CA. The GRC will include plenary sessions on exocrine gland
development, regenerative approaches, functional relevance of salivary proteins, membrane functions in
exocrine glands, understanding the etiology of autoimmune disease, targeting inflammation to retard disease
pathogenesis and current topics in exocrine gland:pathogen such as SARS-CoV2 interactions. Invited speakers
for the GRC will include eminent scientists from academia, industry and government and talks will include both
senior and junior scientists from diverse fields who will present current unpublished research findings on subjects
identified by previous meeting organizers and attendees as of greatest interest to the field. Several keynote
speakers will be invited to deliver seminars on stem cell therapeutics, clinical genomics and clinical trials for
Sjögren's disease, a common autoimmune disease that affects exocrine glands and negatively impacts the
quality of life of patients for whom no suitable and effective therapies are available. A noteworthy feature of this
GRC will be continuation of a GRS to be held just prior to the GRC, first offered in 2017, that will invite only
speakers who are graduate students and postdoctoral associates in a wide variety of laboratories worldwide.
These junior scientists at the GRS will also attend the GRC where many of them will be chosen to give seminars
that will be included in the plenary sessions. In addition, poster sessions will be held daily at the GRC to enable
all attendees to present and discuss their data in an open forum. The overall goal of the GRC and GRS will be
to foster scientific exchanges and engender research collaborations in disciplines that are viewed as having a
major impact on the development of novel strategies to improve human health. Specific Aims in line with the
NIDCR mission include: 1) to present a program of topical interest to scientists in academia, industry and
government and to assemble junior and senior investigators in a pleasant setting where they will have
opportunities to discuss unpublished findings before a knowledgeable audience and engage in a wide range of
critical research discussions; 2) to offer a GRS to be attended by graduate students and postdoctoral associates
who will present their novel research findings before an audience of their peers and; 3) to emphasize
presentations on state-of-the-art methodologies of interest to the exocrine biology field towards the goal of
developing innovative approaches to the improvement of human health by preventing disorders of secretory
organs.

Public health relevance
PROJECT NARRATIVE Exocrine biology includes a variety of secretory organs, including salivary glands, lacrimal glands and the pancreas. Current research is focused on preventing diseases of these tissues, including autoimmune diseases that lead to tissue degeneration, and environmental and genetic factors that lead to the loss of secretory function. The major goal of the GRC and GRS on Salivary Glands and Exocrine Biology is to foster scientific exchanges and engender research collaborations in disciplines related to exocrine biology and disease that will have a major impact on novel strategies to improve human health.